Nuclear Magnetic Resonance Core

The Nuclear Magnetic Resonance (NMR) Core with the existing state-of-the-art instrumentation and techniques is represents a critical part of COBRE to address the following needs of COBRE research programs across the campus ofthe University of Delaware (1) to facilitate the research and development of NMR spectroscopy as a premier method for structural analysis of a wide variety of systems in solution and solid states, and (2) to provide support for structural analyses of small-molecule and macromolecule-based biomaterials in solution and solid states.

Public health relevance
Structural characterization of biomaterials at atomic resolution is critical to the design and optimization of biomaterials. Nuclear Magnetic Resonance (NMR) spectroscopy plays a unique and an irreplaceable role as a method for atomic-scale structural analysis ofvarious kinds of materials. The NMR Core will provide stateof- the-art NMR research instrumentation and expertise to help COBRE investigators gain fundamental insights into the structures of materials under investigation. These studies will ultimately generate materials systems that are optimized for their targeted drug delivery and tissue engineering applications.